Optimization of AEOL10150 treatment of sulfur mustard-induced lung toxidrome in a pig model

Our long term goal is to develop the catalytic antioxidant AEOL10150 as medical countermeasure for sulfur
mustard gas-induced acute lung injury. Sulfur mustard gas is a commonly stockpiled chemical warfare agent
that has been deployed on military personnel and in civilian populations producing mass casualties. Currently
there are no effective treatments for sulfur mustard gas exposure. AEOL10150 uniquely targets reactive
oxygen and nitrogen species that have been implicated in cellular and tissue damage produced by alkylating
agents such and sulfur and nitrogen mustards. We have previously shown that AEOL10150 can protect the
lung against several chemical agent exposures including chlorine, phosgene, soman, and sulfur mustard gases
in rodent models. AEOL10150 is in advanced development as a mitigator of radiation-induced lung injury by
Aeolus Pharmaceuticals. AEOL10150 is in advanced drug development with completed GLP chronic safety
studies in mice and monkeys, completed Chemistry, Manufacturing, and Control (CMC), and a phase 1A
clinical safety trials in humans. The purpose of this UO1 grant is to optimize AEOL10150 dose and delivery in a
swine model of SM-induced acute lung injury as part of the requirements of the FDA Animal Rule. We will
achieve this goal through 3 specific aims. The first aim will establish a swine sulfur mustard inhalation model
that produces acute respiratory injury and mortality within 24 to 48 hours. The second aim will optimize
AEOL10150 pharmacodynamics in the swine sulfur mustard inhalation model. And the third aim will determine
the efficacy of AEOL10150 in a swine model of SM-induced acute lung injury while mitigating mortality. These
studies will allow AEOL10150 to move forward and help design the pivotal safety and efficacy studies needed
for regulatory FDA approval of AEOL10150 under the animal rule. AEOL10150 has the potential to be a broad
spectrum medical counteragent against traditional chemical warfare agents and toxic industrial chemicals that
inflict a lung toxidrome.

Public health relevance
Sulfur mustard gas is a present threat to military and civilian populations with no effective medical countermeasures. The proposed studies will optimize the catalytic antioxidant AEOL10150 in a swine sulfur mustard exposure model. We plan to develop AEOL10150 as a broad spectrum medical counteragent against traditional chemical warfare agents that inflict a lung toxidrome.